Direct quantitation of the circulating Mtb-peptidome for pediatric TB management

ABSTRACT
Conventional methods for adult and pediatric tuberculosis (TB) diagnosis and treatment monitoring rely heavily
on time-consuming bacterial culture or unquantifiable DNA assays to detect the presence of small numbers of
bacteria. Pediatric TB management is particularly difficult because current organism-based methods for
diagnosis and treatment monitoring are resource-intensive, invasive and inadequately sensitive for children,
who tend to have paucibacillary disease. Due their immunological immaturity, young children are at high risk of
rapid disease TB progression, with significant morbidity and mortality. Assessment of their treatment response
relies on subjective measures, limiting children's access to much needed shorter and safer TB regimens. More
rapid and rigorous methods of TB diagnosis and treatment monitoring are thus critically needed for children. In
order to address current limitations in pediatric TB management, we propose to develop a rapid diagnostic
method, independent of mycobacterial isolation, that quantifies the low molecular-weight M. tuberculosis (Mtb)
antigens (CFP-10 and ESAT-6) and the TB-associated host marker IP-10 in patient blood samples. ESAT-6
and CFP-10 are ideal biomarkers to detect active TB and its treatment response, and addition of IP-10 to this
Mtb-specific proteomic pattern will provide an integrated profile of patients' pathophysiological changes during
anti-TB treatment, while also improving diagnostic sensitivity. Our strategy utilizes hollow, energy-focusing
TiO2 NanoShells functionalized with custom antibodies specific for Mtb CFP-10 and ESAT-6 and host IP-10
peptides with high-throughput mass spectrometry (MS) to increase diagnostic sensitivity and specificity. We
evaluated an Mtb-antigen-only version of this NanoShell-MS platform (no anti-IP-10 NanoShells) with 292 adult
and 102 pediatric patients and controls chosen from five highly relevant cohorts (adult, pediatric and latent TB,
HIV/TB co-infection, and non-TB mycobacterial infection), from our global collaborators. NanoShell-MS
sensitivity and specificity for active TB (bacteriologically confirmed and clinically diagnosed) were, respectively,
90.7% / 97.7% in adults and 88.2% / 100% in children, with 78.6% sensitivity in culture-negative pediatric TB
patients, greatly exceeding the WHO's published 4-15% Xpert sensitivity in this cohort. NanoShell-MS results
can be obtained within one hour of sample collection compared to 4-6 weeks for conventional culture, and
detected decreases in blood Mtb antigen levels within four days of anti-TB treatment initiation. In this proposal
we aim to 1) use NanoShell-MS profiling to develop a quantitative prediction model for active TB diagnosis in
large, well-described prospective pediatric TB cohorts and 2) determine the utility of our approach for rapid
evaluation of treatment efficacy. Our NanoShell-MS assay platform has the advantage that it uses accurate,
high-throughput mass spectrometry, which has become a critical means for clinical diagnosis in many parts of
the world, while integration of our NanoShell-MS platform with an easy-to-use “miniaturized” (shoebox size)
MS system which should also allow this approach to serve pediatric patients in resource-limited areas.

Public health relevance
NARRATIVE Diagnosing pediatric tuberculosis (TB) and evaluating its timely response to therapy is extremely challenging, since it can be very difficult to obtain necessary samples, and these tend to have poor diagnostic value, but early detection is critical in reducing morbidity and mortality, while treatment monitoring may identify children who would respond better to novel treatment regimens minimizing side-effects and treatment duration. In this project we use a novel nanoparticle-based method to detect blood levels of two TB and one host-response protein released during active TB disease in order to diagnose and monitor pediatric TB using easy-to-obtain small-volume blood samples. Based on our preliminary results, we are confident that this strategy has great potential to: 1) promote early detection of active pediatric TB to decrease progression and improve outcomes, and 2) permit rapid monitoring of pediatric TB therapy, which may allow physicians to personalize a child's treatment to avoid unnecessary exposure to toxic TB drugs once the child has cleared their TB infection.